METAVEST: Advanced Biomimetic Personal Cooling for Enhancing Heat Safety Among High-Risk Workers

SUMMARY
Rising temperatures from climate change are impacting workers across various sectors in the U.S., leading to
reduced productivity, significant economic costs, and placing employee lives at risk. Current approaches to
combat heat exposure, such as protective clothing, scheduled breaks, hydration protocols, and shaded or
ventilated areas, have significant limitations to provide protection. Advanced active cooling systems incorporating
thermoelectric or conventional refrigeration offer substantial cooling but are energy-intensive and prohibitively
expensive, costing thousands of dollars per unit, making them inaccessible to industry workers who would benefit
the most. These limitations highlight the need for high-performance, lightweight personal cooling systems that
ensure day-long heat safety. Our solution is a high-performance, biomimetic personal cooling system (PCS) that
revolutionizes personal heat safety and address the limitations of current cooling vests. The cooling vest utilizes
highly thermally conductive gallium alloy-based liquid metal (LM) as the primary coolant and ice as the secondary
coolant to significantly reduce heat-related health risks for workers. The potential of METAVEST is anchored in
four key success metrics: efficient cooling capacity (200-400 W-hr), sustained performance (4-8 hrs), lightweight
design (3-8 lbs), and affordability (<$400/unit). Our approach inspired by human heart capillaries, allows for
controlled and efficient cooling, adaptable to user needs through variable pump speeds. Unlike passive systems,
the vest maintains consistent cooling efficiency, making it a superior choice for prolonged and effective body
temperature regulation for U.S. workers in extreme heat.

Public health relevance
Project Narrative Rising temperatures from climate change are impacting workers in the United States leading to reduced productivity, significant economic costs, and placing employee lives at risk. While current approaches to combat heat exposure have significant limitations; our approach seeks to utilize a high-performance, biomimetic personal cooling system (PCS) inspired by human heart capillaries to enhance heat transfer efficiency. By offering superior cooling capacity, extended duration, lightweight construction, and affordability, our PCS sets a new standard in personal cooling technology for enhanced heat safety and improved work performance.